Effects of COVID-19 on Daily Lives of Older Persons with and without ADRD: National Health and Aging Trends Study Supplement

Abstract This application funds a supplement to the National Health and Aging Trend Study (NHATS) to study the effects of COVID-19 on the daily lives of older adults with and without Alzheimer's Disease and Related Dementia (ADRD). NHATS interviews a national sample of older adults annually in order to (1) promote scientific inquiry into late-life disability trends and dynamics, their antecedents and correlates, and disparities therein and (2) to advance study of the social and economic consequences of late-life disability for individuals, families, and society. The overarching purpose of this supplement is to design, collect and disseminate new data about older adults' adaptation of their daily lives to the COVID-19 pandemic and consequences for care needs and wellbeing of those with and without ADRD, drawing on the dual perspectives of older adults and their helpers. The specific aims of this supplement are to: 1) Design and administer a COVID-19 mail out/mail back supplement to NHATS 2020 (expected sample sizes=3000-3100 NHATS participants including 600 with probable or possible dementia; and 2900-3000 family and unpaid helpers including 900 assisting an older adult with probable or possible dementia); 2) Disseminate a set of rapid release NHATS-COVID-19 public use files and documentation, a set of final NHATS-COVID-19 files and documentation and a set of transcripts to support qualitative analysis of the open-ended item about COVID-19's effects; and 3) Conduct targeted analysis of the rapid release COVID-19 items to create a portrait of daily lives and wellbeing of older Americans with and without ADRD during the outbreak and the family members and unpaid helpers who assist them. The activities proposed for this supplement will facilitate both short- and long-term understanding of the implications of the COVID-19 pandemic for the care needs and wellbeing of older adults, and how these unfolded differently for those with and without dementia.

Public health relevance
Narrative This application funds a supplement to the National Health and Aging Trend Study (NHATS) to study the effects of COVID-19 on the daily lives of older adults with and without Alzheimer's Disease and Related Dementia (ADRD). The overarching purpose is to design, collect and disseminate new data about older adults' adaptation of their daily lives to the COVID-19 pandemic and consequences for care needs and wellbeing of those with and without ADRD, drawing on the dual perspectives of older adults and their helpers.